PROCUREMENT OF PROSTATE TUMOR TISSUES

The primary objective of this project is to secure tissue from CaP patients (during the course of their diagnosis and treatment) for the purpose of biological studies designed to characterize cancers with respect to their biological potentials. Frozen samples as well as paraffin-embedded samples of prostate tissue will be provided for study at the University of California-Davis laboratories for DNA quantitation. It is expected that the results obtained will be helpful in the prognostication aspects of the CaP population. Ethnic differences may be defined by the studies also. Approximately 100 cancer patients are expected to enter the study.